Development of practical screening tools to support targeted prevention of early, high-risk drinking substance use

PROJECT SUMMARY
This application is for an administrative supplement to DA058314, Development of practical screening tools to
support targeted prevention of early, high-risk drinking substance use. The purpose of the supplement is to
preserve, generalize, document, and disseminate a unique research material we have developed for the
DA058314 project. Namely, we aim to create an open-source toolkit of bespoke metadata, code, and
workflows that will allow end-users to quickly create and evaluate practical instruments for screening or
prediction of any outcome of their choosing in the ABCD Study. Today, the breadth and complexity of the
ABCD Study poses a major barrier to outside users pursuing the development of screeners or other prediction
instruments. By lowering these barriers, the toolkit we develop will unlock the unprecedented potential of the
ABCD Study for developing accurate, equitable approaches to risk estimation and prediction, in turn improving
the ability of clinicians, policymakers, and scientists to allocate resources efficiently. We will disseminate the
toolkit via a free R package, a website, peer-reviewed publications, and webinars. The administrative
supplement is needed to support an additional staff member whose time will be devoted to these activities and
complete this work in parallel to ongoing work on the parent award.

Public health relevance
PROJECT NARRATIVE This administrative supplement to DA058314, Development of practical screening tools to support targeted prevention of early, high-risk drinking substance use, will enhance public health by facilitating the creation of an open-source toolkit for developing practical screening instruments using ABCD Study data. Accurate screening instruments can help clinicians and scientists estimate risk, triage families, and allocate resources more efficiently.